Characterization of Gastric Evoked Potentials

Project Summary: Motor evoked potentials (MEPs) elicited via non-invasive electrical stimulation of the
human brain are the foundational basis for investigating the neural circuits that link cortical output to the spinal
cord and muscles. Transcranial magnetic stimulation (TMS) methods have allowed the study of the
organization and plasticity of motor control systems by monitoring MEPs in awake human subjects, with
insights leading to myriad clinical applications for assessing and treating motor dysfunction. In stark contrast to
MEPs from peripheral skeletal muscle, there is no comparable, objective measure of central neural influences
on the smooth muscles of the gastrointestinal tract. This fundamental barrier has hindered progress in
neurogastroenterology by limiting the ability to study the organization and plasticity of cortical influences on the
neural control of the GI system in awake human subjects. To overcome this barrier, we have recently
developed a direct electrophysiological readout of a neural circuit linking the cortex to the stomach that we call
gastric evoked potentials (GEPs). GEPs are generated by coupling TMS with cutaneous
electrogastrography (EGG), which provides a continual electrophysiological readout of gastric smooth muscle
activity. Our pilot studies demonstrated distinct GEP signals resulting from TMS stimulation of the primary
motor cortex (M1) in human subjects. Analogous to the fundamental role TMS-elicited MEPs have had in
guiding the exploration of the neural control of movement, TMS-elicited GEPs will guide the exploration of the
neural control of GI movement (i.e. `gut motility'). In this project, we seek to determine and standardize how
best to record GEPs, to optimize the TMS parameters and conditions necessary to evoke GEPs, and to identify
the location of cortical sites that most readily generate GEPs (`GEP hotspots') (Aim 1). We then will assess
whether various modes of repetitive TMS (rTMS) neuromodulation (inhibitory 1Hz or stimulatory 10Hz)
targeted to GEP hotspots shape gastric motor responses (Aim 2). This preliminary clinical research will
develop GEPs as a non-invasive, direct measure of the neural circuit linking the cerebral cortex to the control
of the stomach, with similar reliability and reproducibility to methods used to elicit MEPs. Our work will guide
the development of TMS as a tool for mechanistic studies of gastric physiology in human subjects and brain-
based methods to manipulate stomach function. This line of work could lead to clinical trials of TMS
neuromodulation, directed to cortical sites identified as inducing maximal GEP responses, to treat gastric
motility disturbances that arise in a variety of clinical contexts.

Public health relevance
Project Narrative: This project uses non-invasive brain stimulation techniques in normal subjects to define a novel electrophysiological measure of a neural circuit linking cortical output to the control of the stomach. We will use cortical neuromodulation of this neural circuit to shape gastric motor responses. This line of work lays the foundation for developing brain-based approaches to influence gastric function with broad applications, including future cortical neuromodulation-based therapies for gastric motility disorders.